OHSU Knight Federated Learning Network Prototype to Support Multimodal Cancer Models

PROJECT SUMMARY/ABSTRACT
Traditional data-sharing models typically centralize de-identified data for analysis. Patient
records have become more multifaceted and high-dimensional such that de-identification alone
is inadequate to safeguard privacy. Privacy violations can result in harms to patients that can be
both deontological (ethically problematic) or consequentialist (harm such as discrimination,
financial consequences, and stigma). Current regulatory guidelines are not designed for the
complexity of AI/ML. Moreover, each academic medical center will have their own ethics boards,
governance models, privacy standards and security requirements. Risk of a privacy breach
limits access and sharing of patient data — a barrier to research across cancer centers and
academic medical centers. Given its outstanding strengths in precision oncology, computational
biology, machine learning, clinical curation, data governance and data quality and regional data
sharing, OHSU Knight Cancer Institute is uniquely situated to assist NCI in the development of a
federated learning network. The long-term objective is to develop the best practices and
guidance to support large-scale federated learning across cancer centers to achieve optimal
benefit through broad data sharing. In the near term, the focus of this project is to support the
development and testing of a federated learning network prototype. To do this, the OHSU
Knight Cancer Institute proposes the following aims. Aim 1 is to develop a multi-modal deep
learning model to predict tumor mutational burden in prostate cancer. Aim 2 is to implement and
evaluate our federated learning prototype focusing on privacy, compliance and bias reduction.
This will also include assessment of the impact of adversarial attacks and how well different
defense strategies mitigate this. Finally, Aim 3 is the evaluation of the federated model on the
federated learning network in collaboration with partner sites (other cancer centers, NCI).

Public health relevance
PROJECT NARRATIVE There are numerous challenges which hamper data sharing across cancer centers. Federated learning is a promising approach which may mitigate many of these challenges (privacy, compliance, security). This work will implement and evaluate a federated learning network with an initial use case focused on prostate cancer, which can inform future use of this approach by cancer centers and medical centers across the country.